Role of Circadian Misalignment in Beta-cell Failure in Type 2 Diabetes

PROJECT SUMMARY/ABSTRACT
Pancreatic β-cell failure in a distinctive feature of Type 2 diabetes mellitus (T2DM) and therefore preservation of
β-cell health has been identified as a critical barrier for the development of successful preventative and treatment
strategies in T2DM. Primary features of β-cell failure include insulin secretory dysfunction, loss of transcriptional
identity/β-cell dedifferentiation, and β-cell loss, with growing evidence pointing to impaired endoplasmic reticulum
(ER) proteostasis as a key driver of this process. Recent evidence suggests that environmental stress conditions
that produce disruptions of daily fasting/feeding circadian cycles (i.e. circadian disruption, CD) lead to glucose
intolerance, hyperglycemia, and promote β-cell failure in T2DM. However, the molecular mechanisms underlying
circadian control of β-cell function and ER proteostasis remain unknown. In this regard, our preliminary studies
determined that CD-mediated abrogation of normal fasting/feeding cycles is a potent physiological inducer of β-
cell functional failure, and this process is molecularly mediated through loss of β-cell expression/activity of
circadian transcription factor D-box binding PAR bZIP transcription factor (Dbp). Therefore, the key objective of
the proposal is to test the hypothesis that Dbp is an important regulator of β-cell circadian function through
rhythmic activation of transcripts regulating insulin secretion and ER proteostasis, whereas loss of Dbp
expression, as occurs in β-cells in response to circadian disruption and diet-induced obesity, promotes β-cell
functional decline in T2DM. To address this, Specific Aim 1 will utilize novel conditional genetic loss and gain-of-
function Dbp mouse models to establish a causative relationship between circadian Dbp expression and the
regulation of β-cell function, ER proteostasis, and transcriptional identity. In addition, we will also examine
whether Dbp regulates β-cell function and transcription in human β-cells utilizing viral gain/loss of function
techniques concurrent with transplantation of human stem cell-derived β-cells into immunodeficient mice.
Specific Aim 2 will utilize β-cell-specific Dbp luciferase reporter mice and systems biology multiomics approaches
(RNAseq + scATAC seq) to 1) identify molecular mechanisms by which obesity disrupts circadian regulation of
Dbp expression and corresponding β-cell circadian clock function, and 2) test novel strategies designed to
restore normal functionality of β-cell circadian clocks in obesity as means to prevent β-cell failure in T2DM. Taken
together, successful completion of proposed studies will uncover novel molecular mechanisms through which β-
cells integrate and respond to circadian changes in nutritional availability and will provide potential therapeutic
targets for prevention and treatment of T2DM.

Public health relevance
PUBLIC HEALTH RELEVANCE/NARRATIVE Type 2 diabetes mellitus (T2DM) is one of the major health problems facing today’s society and projected to afflict nearly 1 in 3 people by year 2050. It is therefore critical to improve our understanding of the molecular mechanisms driving the increasing prevalence of T2DM which can lead to the development of novel therapeutic and preventative approaches. Thus the underlying goals of this proposal are to uncover novel molecular mechanisms responsible for the regulation of pancreatic β-cell function in people exposed to enviromental stressors associated with increased risk of T2DM such as circadian rhythms disruptions and diet induced obesity.